Stroke Trials Network of Columbia and Cornell

The Stroke Trials Network of Columbia and Cornell (STNCC) has a primary goal of
maximizing stroke clinical trial enrollment for New York. Columbia and Cornell, situated on the
west and east side of Manhattan, respectively, will form the two hubs, supported by an Acute
Treatment Sub-network of 3 hospitals in Brooklyn and New Jersey, a Recovery Sub-network
comprising 2 affiliated academic Rehabilitation Centers in Westchester County and New Jersey,
and 4 Academic Medical Centers in Brooklyn and in Western New York. Our hubs and satellites
treated just over 6,700 strokes in 2016. More importantly, our RCC has an extensive leadership
record in stroke clinical trials, and have the distinction of being the leading enroller in Stroke
clinical trials over the first 5 years of StrokeNet; Our total enrollment as of August, 2017 was 375
subjects. Historically, over the last 10 years, Columbia and Cornell have been involved in 44
human stroke studies, including 29 stroke clinical trials, 10 stroke biomarker studies, and 5
stroke outcomes studies. The demographics in our network overall are very favorable for
enrolling underserved minority populations: Columbia has 40% Hispanic and 25% African
American; Cornell 15% Asian, and St. Joseph's 24% African American, 30% Hispanic, 12%
other. Part of our success is due to the highly organized and interactive infrastructure. We hold
monthly videoconferences attended by PIs and coordinators from all RCC hubs and satellite
sites, and standardized daily stroke admission screening across the RCC. These data as well
as trial enrollments are reviewed at the monthly videoconference calls. The STNCC has also
provided leadership at the national level in the first 5 years of StrokeNet. Contact PI Randolph
Marshall served on the NCC Executive Committee for the first 3 years, as Co-Chair of the
Education and Training Core for all 5 years, and on the Recovery and Rehabilitation Working
Group over the last year. He has been invited to continue the latter two roles in the upcoming
renewal period. Co-I Ronald Lazar, now at UAB, served on the Recovery and Rehab WG for
three years, and Co-PI E Sander Connolly has served on the Neurosurgery advisory group. In
terms of innovation and clinical trial development, our RCC has the distinction of submitting
and obtaining funding for two of the new StrokeNet studies. STNCC Co-Is Mitchell Elkind and
Hooman Kamel are Co-PI's on the ARCADIA trial, a multi-center Phase 3 RCT to determine
whether apixaban is superior to standard therapy for patients with cryptogenic stroke and “atrial
cardiopathy.” Randolph Marshall, Sander Connolly, and Ronald Lazar are Co-PI's on the
CREST-H study, an ancillary study to the CREST-2 trial, testing the hypothesis that
revascularization can improve cognition in as subset of patients with high grade asymptomatic
carotid stenosis who have cerebral hemodynamic failure. Finally, our StrokeNet trainee program
has been highly successful, with 5 trainees producing 22 abstracts and 21 manuscripts within 1
year of Fellowship, and 4 so far have Assistant Professor positions at major academic
institutions (all StrokeNet sites). Two are applying for K-awards.

Public health relevance
Stroke is the 4th leading cause of mortality and the leading cause of disability for adults I the US. The Stroke Trials Network of Columbia and Cornell (STNCC) will continue to provide leadership and productivity within the NIH StrokeNet program. Developing, implementing, and completing nationwide multicenter randomized controlled trials for stroke treatment will benefit our US population by reducing the burden of this devastating disease.